Elucidating and targeting beta-cell senescence and its SASP

Abstract
This proposal seeks to elucidate the mechanisms of β-cell senescence, an aging hallmark, as a contributor to
type 2 diabetes (T2D) and identify optimal therapeutic targets. Pancreatic insulin secreting β-cells, crucial to
glucose homeostasis, are heavily secretory cells, equipped to respond to small changes in blood glucose
levels and highly susceptible to stress by nutrient overload. My work has identified that mouse and human β-
cells undergo senescence in response to insulin resistance (IR), leading to loss of cellular identity, impaired
function and secretion of a unique senescence-associated secretory phenotype (SASP). Additionally, I showed
that senolysis improved blood glucose levels and recovery of β-cell function and identity. I hypothesize that
cellular senescence and its SASP are targetable drivers of β-cell dysfunction and loss. My goals are to
understand the mechanisms behind β-cell senescence and identify the optimal therapeutic strategy. Aim 1.
Identify the cell autonomous driver(s) of β-cell senescence and its functional effects. Based on our
models of IR and DNA damage, we hypothesize that cyclin-dependent kinase inhibitor p21Cip1 is upregulated
early in β-cell senescence and is followed by p16Ink4a. Genetic gain- and loss-of-function strategies will be used
to compare the effects of p21Cpi1 and p16Ink4a on mouse and human β-cell function, identity and SASP.
Additionally, the functional changes of senescent cells will be pinpointed. This aim will define the cell
autonomous molecular mechanism(s) that drive β-cell senescence and its functional consequences. Aim 2.
Elucidate the non-cell autonomous effects of the β-cell SASP. The hypothesis is that β-cell senescence
can be driven by a non-cell autonomous mechanism through SASP factors, capable of impairing the function
and gene identity of neighboring cells and precipitating their entry into senescence. To evaluate the effects of
SASP upon neighboring β-cells, we will test the effects of the overall and specific selected factors on insulin
secretion, senescence status and gene expression. Additionally, we will test the temporo-spatial effects of
SASP on neighboring cells using our p21Cip1-dTomato Red MIP:GFP reporter mice. This aim will test the
effects of β-cell SASP on non-senescent cells. Aim 3. Compare the effects of senolytic and senomorphic
drugs in the recovery of β-cell function and identity. In our previous studies, senolysis effectively restored
β-cell function and identity but a decrease in the number of senescent cells (senolysis) may be detrimental to
an already inadequate beta cell mass, so perhaps only inhibiting their SASP (senomorphic effect) would
render similar beneficial results. The hypothesis is that senormorphic drugs will restore β-cell function and
identity without impacting cell mass. This aim will compare the effects of senolytic and senomorphic drugs on
islets of human donors that have one or more of the following characteristics impairing glucose metabolism:
older age, IR and T2D. This aim seeks to identify the optimal pharmacological mechanisms to recover the
function and cellular identity without mass impairment.

Public health relevance
PROJECT NARRATIVE This proposal focuses on understanding the mechanisms of pancreatic β-cells senescence and the optimal strategy to therapeutically target them. Cell autonomous and non-cell autonomous mechanisms will be studied in biologically relevant models such as primary human and rodent islets. Achievement of the proposed aims will advance our knowledge of senescence biology in a highly metabolically relevant cell type with important implications for type 2 diabetes mellitus.